SBIR TOPIC 111, PHASE I, OXYGEN DELIVERY DEVICE INNOVATIONS

The contractor will develop and work towards commercializing a light weight continuous flow Portable Oxygen Device that is available for clinical and investigational care of patients. The goal is to develop a lightweight, Portable Oxygen Device, with a continuous flow of oxygen of at least 5 liters per minute, and provide pulsed oxygen at a rate equivalent to 5 liters per minute of continuous flow. Remote control of the device should allow adjustments without taking the Portable Oxygen Concentrator (POC) off. The POC is to be designed for use during domestic and international travel.